Tear protein biomarkers of refractive surgery pain

PROJECT SUMMARY
Photorefractive keratectomy (PRK) and laser-assisted in situ keratomileusis (LASIK) are
surgical procedures used to correct refractive errors, with approximately 600,000 surgeries
performed in the United States each year. A proportion (10 - 20%) of individuals develop
persistent ocular pain after refractive surgery, which is a source of tremendous morbidity,
limiting the ability to work, impacting mental health, and leading to suicidal ideation in severe
cases. We hypothesize that proteins in the tear fluid modulate corneal nerve function,
increasing the risk of and contributing to persistent pain after refractive surgery. As such, our
studies will use proteomic analysis of tear fluid after surgery to identify diagnostic biomarkers for
persistent ocular pain. We will also examine tear proteins prior to surgery in an effort to identify
prognostic biomarkers that predict which individuals are likely to develop persistent pain after
surgery. R33 Phase studies will use an alternative proteomics platform for analytical validation,
and an additional new patient population for clinical validation. This knowledge can lead to
better preventative and therapeutic algorithms to combat this debilitating condition and thus
improve quality of life and decrease patient suffering.

Public health relevance
Narrative Refractive eye surgery, including photorefractive keratectomy (PRK) and laser-assisted in-situ keratomileusis (LASIK), leads to persistent pain in some individuals that negatively and significantly impacts quality of life. Our studies will examine whether proteins in tear fluids collected before and after surgery can identify a biomarker signature that is predictive and diagnostic of persistent corneal pain after eye surgery.